Pilot Core (Aging Focus): Technology Development and Refinement

The goal of Pilot Core for Aging (PCB) is to utilize a multidisciplinary collaborative approach to identify,
develop, refine, and disseminate promising technologies that have high potential to improve the health and
wellbeing of older Americans and/or their caregivers, with an emphasis on those that can mitigate current
disparities in access and delivery of health care in rural and urban areas across the US. The aims of this core
are to identify and fund innovative AI and machine learning-supported technologies that promise to improve the
health and well-being of older without Alzheimer's Disease through an annual pilot award process, to ensure
awarded pilot projects are well-designed, timely and rigorous, to assist in the further development and
translation of completed pilot projects into products that will benefit older adults and/or their caregivers, and to
expand the expertise and network of funded investigators focused on aging relevant AI technologies. Pilots will
be solicited from investigators across the US, and developed, refined, and supported within a series of cores
that will help to connect older adults stakeholders, tech and AI expertise, Geriatricians and Alzheimer's disease
(AD) experts, clinical researchers, business and venture capital leaders, and rural and urban health experts.
This core will be tightly integrated with the other cores in order to assure that the best ideas and technologies
are identified, optimized, tested, and piloted by support from the entire AITC. Through close collaboration with
the Networking and Mentoring Core and relevant consortia, pilot project ideas and results will be
communicated to key stakeholders, decision-makers, and business leaders with potential to promote the
development of products and move them to practice. Pilot investigators will be fully integrated into all activities
as described in Technology Identification and Training Core (TITC) and Networking and Mentoring core (NMC)
through all phases of research and will have access to technical, environmental, and scientific resources
available in this AITC.